Novel tools for screening retinal function using improved human retinal organoid models

Project Summary/Abstract
Treating retinal degenerative diseases has been hampered by the lack of suitable systems that can
evaluate how new treatment strategies affect the function of the human retina. Human stem cell-derived 3-
dimensional retinal organoid technologies have been recently developed. Remarkably, human retinal organoids
mimic the native tissue's histological organization, cellular composition, and are able to respond to light. These
organoids are an ideal model system for investigating novel therapies to treat blinding diseases. However, to
fully realize the unprecedented potential of human retinal organoids for the development of treatments for retinal
degenerative diseases, we need new technologies that can rapidly measure retinal function under a wide variety
of conditions.
Current techniques such as patch-clamp electrophysiology, calcium imaging, and multi-electrode array
recordings, measure how individual cells function within the circuitry of the retina. However, these techniques
are laborious and ineffective at assessing the health, reproducibility, and functional responsivity of the retina as
a whole - features that are key to the application of organoid systems to drug screening and validation. The lack
of a device and techniques that allow for rapid, non-invasive screening of the functional status of retinal organoids
constitutes a major unmet need. In Aim 1 of this proposal, we will develop an electroretinogram (ERG) recording
chamber and a recording protocol for real-time assessment of light-evoked retinal organoid physiology by
measuring photoreceptor and bipolar cell function. Our findings will be used to establish critical metrics
associated with normal organoid light-evoked responsivity. Further, we will evaluate the power of this approach
to detect changes in photoreceptor function, to provide evidence of its applicability to the assessment of disease
models and therapeutic screening.
To take full advantage of this technology for downstream applications it is critical that it be combined with
robust organoid models. The variability and low yield of current protocols for retinal organoid generation and the
extended time required for functional maturation of organoid photoreceptors hinder their application in drug
development and disease evaluation. In Aim 2 of this proposal, we will address this critical gap by developing
and evaluating improved protocols for human retinal organoid generation that increase yield and accelerate
photoreceptor differentiation. We will then evaluate retinal function in these improved organoids using our ERG
platform.
Through the combination of these technologies, we will have created the first system for rapid, non-
invasive functional screening in human retinal organoids that can be applied to the evaluation of normal,
diseased, and drug-treated conditions. Our system has the potential to greatly accelerate the development of
novel therapies to reverse vision loss.

Public health relevance
PROJECT NARATIVE: To fully realize the unprecedented potential of human retinal organoids for the development of treatments for retinal degenerative diseases, we need robust organoid models and new technologies that rapidly measure retinal function under a wide variety of conditions. By combining these technologies, we will, for the first time, assemble a robust system that allows researchers to test how diseases and potential treatments affect the function of the human retina in a rapid and non-invasive manner.